Microscopy Laboratory Shared Resource

Abstract/Project Summary
Microscopy (MICROS)
The Microscopy Core Lab Shared Resource (MICROS) is a new Shared Resource that provides
state-of-the-art, comprehensive light and electron microscopy imaging to PCC investigators.
Under the expert direction of Dr. Feng-Xia (Alice) Liang, the mission of MICROS is to bring
imaging and image analysis tools, ranging from angstroms to centimeters, to PCC members
regardless of their pre-existing expertise, and to provide assistance at every stage from
experimental design through execution and analysis to final presentation. MICROS staff learn
from PCC members what are the scientific questions they hope to address through imaging and
advise them about imaging technologies. When needed, MICROS staff develop new protocols,
including those that integrate with other PCC shared resources, especially Experimental
Pathology and Applied Bioinformatics Laboratory. In addition, as an imaging hub, MICROS
serves as an initiator of collaboration among PCC investigators by means of three Specific
Aims: Aim 1) To provide PCC members with cutting edge imaging technologies; Aim 2) To
determine the best imaging techniques to address the specific scientific questions of PCC
investigators; Aim 3) To maintain PCC light microscopes and provide expertise needed to
catalyze PCC collaboration with the newly established cryoEM services.